University of Minnesota Clinical and TranslationalmScience Institute (UMN CTSI)

Contact PD/PI: Blazar, Bruce
A. Overall: Abstract. The University of Minnesota's Clinical and Translational Science Institute's (UMN
CTSI) vision is a world where impactful discoveries leading to the betterment of human health occur by
bringing together Academic Health Center (AHC) research with community outreach and industry
partnership. Our mission is to create a nationally-recognized, shareable model of complex translational team
science driven and enabled by integration and alignment of clinical and translational science (CTS) research
with education, data access, community needs, and industry efforts. In the past 6 years, CTSI 1) Developed
comprehensive programs for workforce training and fostering career development for the next generation of
CTS research investigators; 2) Created Community Engagement to Advance Research and Community
Health (CEARCH) to support stakeholder community contributions to CTS research and to tackle health
outcome disparity challenges in Somali, Latino, Native American, Hmong, and other populations; 3)
Leveraged UMN research strengths and MN's vibrant biomedical industry to advance multiple projects along
the commercialization pathway; and 4) Expanded its patient base from the UMN tertiary care adult and
pediatric hospitals to hub partners consisting of a VA hospital, a community-based 7-hospital system, and a
safety-net county hospital with 65% racial/ethnic minorities linked with i2b2/SHRINE for cohort identification.
CTSI formed an unprecedented partnership with Mayo CTSA to provide statewide coverage in CTS
research and education and is a founding member of the Midwest Area Research Consortium for Health, the
Accrual to Clinical Trials federated cohort discovery consortium, and PCORnet Greater Plains Collaborative.
To accelerate and improve CTS research and education and make lasting impacts on healthcare outcomes,
we will pursue the following aims: 1. Train an outstanding multidisciplinary, diverse workforce across the
CTS research spectrum skilled in and rewarded for team science using existing and new educational
offerings; 2. Streamline methods and processes to increase local and national CTSI hub research capacity
in a new Clinics and Surgery Center learning health system with CTSI-led research process design, CTSI's
new StudyFinder tool, user-friendly IRB-approved consent form for clinical and laboratory research, bioinfor-
matics tools, biospecimen collection, and a transformative Clinical Research Support Center for one-stop,
single location, parallel processing of needed approvals; 3. Engage communities and stakeholders through
CEARCH to improve translation and healthcare delivery across the lifespan and to a diverse population; and
4. Add unique contributions to the CTSA network by the Office of Discovery and Translation , Pediatric
Device Innovation Consortium, and high and ultrahigh magnetic resonance imaging and spectroscopy
applications and training. Impact. Connected to and driven by its vision and mission, CTSI will provide
infrastructure and services for conducting innovative, high-impact and efficient, high-quality CTS research.
Project Summary/Abstract Page 391
Contact PD/PI: Blazar, Bruce

Public health relevance
Project Narrative The University of Minnesota's Clinical and Translational Science Institute (UMN CTSI) aims to create a nationally-recognized, shareable model of complex clinical and translational team science (CTS) driven by integration and alignment of CTS research with education, data access, and community and industry partnership. In pursuit of this aim and widespread health improvement, the CTSI will develop new CTS technologies and training programs, ensure CTS research of the highest quality and ethical standards, prepare investigators to be successful as the next generation of national CTS leaders, and create opportunities for CTS researchers to directly involve community members in all stages of their research. The CTSI will also focus on reducing health disparities by bringing clinical research to local underserved populations, advancing research to successful commercialization, and sharing unique UMN assets with the national consortium. Project Narrative Page 392